A culturally tailored anti-inflammatory diet for Hispanic patients with ulcerative colitis

PROJECT SUMMARY
Ulcerative colitis (UC) is on the rise globally, including among Hispanic/Latinos (H/L). Despite growing evidence
of the importance of diet in UC, few clinical trials have examined the impact of diet on inflammation–especially
among H/L. The long-term goal of our team is to develop evidence-based, personalized dietary treatments for
UC that consider individual patient-factors including cultural food preferences to improve both disease
inflammation and adherence. From our pilot data, we have evidence that cultural, native diets may help to
decrease disease inflammation compared to Western diets and that stool microbiome signatures may provide
guidance on future flares. We also have pilot data from my K23 cohort suggesting that H/L patients with UC carry
polyunsaturated fatty acids (PUFA) pathway genetic variants in enzymes that alter the imbalance of n-6 to n-3
PUFA ratios in the blood and tissues. These levels in prior studies have been associated with UC risk. The
overall objectives of this study are then to test the effect of a culturally tailored low fat (1:1 ratio of n-6 to n-3),
high fiber diet on disease remission in H/L patients with mild to moderate UC. We will also will test whether
baseline individual factors such as the stool microbiome composition and circulating blood levels of PUFAs
impact diet-mediated inflammation. The central hypothesis is that patients will have a greater likelihood of
achieving disease remission by week 8 on the culturally tailored diet than when on their usual diet. Further,
individual factors such as stool microbiome composition and PUFA blood levels will predict response to diet
therapy. The central hypothesis will be tested by pursuing three specific aims: 1) Determine the effect of a
culturally tailored anti-inflammatory Hispanic diet on UC inflammation; 2) Identify the stool microbiota
composition and functional metabolites underpinning the relationship between diet and UC inflammation; and 3)
Evaluate the influence of PUFA metabolism on UC inflammation. Under the first aim, we will evaluate the efficacy
of a culturally tailored, high fiber and low-fat diet using a cross-over design on 122 patients with mild to moderate
UC. Our primary outcome will be clinical and biochemical remission using the validated simple clinical colitis
index (SCCAI) and Fecal Calprotectin (FC) at week 8. Patients will receive catered meals for the diet intervention
and stipends for groceries when on placebo diet. Under the second aim, we will examine microbiota abundance
and microbiota-derived metabolites at baseline and that associate with changes occurring from the diet
intervention and among responders/non-responders to diet. The third aim examines the influence of PUFA
metabolism (including PUFA serum levels) as predictors of disease inflammation and response to diet. The
proposed research is significant because we are developing an evidence-based anti-inflammatory diet for UC
tested in a controlled clinical trial that also considers cultural foods, which is unprecedented in prior studies. Our
research is innovative because it is the first attempt to tailor dietary therapy in UC that examines individualized
predictors of response to diet.

Public health relevance
PROJECT NARRATIVE This cross-over study will test a culturally-tailored diet for Hispanic/Latino (H/L) patients with ulcerative colitis and determine predictors of response to diet therapy, including stool microbiome composition and polyunsaturated fatty acid (PUFA) metabolism. By the end of this study, we seek to gain a better understanding of the role of individual patient factors as biomarkers of response to diet and to develop a blueprint for the development of anti-inflammatory culturally tailored diets for patients with inflammatory bowel disease (IBD). The findings from this study may guide food-based recommendations based on cultural background, stool microbiome makeup, and an individual’s capacity for PUFA metabolism.